Emergency Brain Monitor with Telemetry

DESCRIPTION (provided by applicant): The proposed program is meant to provide for the brain what we have been doing for the heart for decades. We will design an advanced device using 21st century technology to monitor the brain (EEG) with a small lightweight wireless, monitor. It can be used in the emergency room, in a prehospital setting, or anywhere in the hospital, including the OR and ICU. The telemetry allows the patient to be untethered and moved about freely while still being monitored. LAN and Internet connections allow a neurologist to be able to read the EEGs from anywhere in the world. FDA approved wireless EEC equipment will be upgraded with new software and electrode harnesses for use in Emergency Departments at Vanderbilt and the University of Illinois, Chicago. The devices will be tested in the ED and a next generation device will be developed. Special attention will be given to design features to allow easy use in the ED environment. The patient testing will be to determine the prevalence of no convulsive seizures of patients with altered mental status in the ED.